Regulators of retinal metabolism in healthy and degenerating retinas

Abstract: The retina has high metabolic activity, and retinal degenerations have been associated with mitochondrial dysfunction, dysregulation of metabolism, and toxic oxidative damage. However, little is known about how metabolism is maintained under normal conditions or is dysregulated in degenerating retinas. AMPK (AMP- activated protein kinase) is a key regulator of metabolism in highly metabolic tissues and is a candidate to regulate metabolism in photoreceptors, and its role in retinal metabolism will be rigorously studied in this proposed project using both gain-of-function and loss-of-function approaches. Peroxisome proliferator-activated receptor gamma coactivator-alpha (PGC-1?) and beta (PGC-1?) are key regulators of mitochondrial biogenesis. Adenosine monophosphate dependent kinase (AMPK) is an important regulator of PGC-1 activity. Our goal in this study is to determine the roles of AMPK and PGC-1 activity in retinal photoreceptors.

Public health relevance
Narrative Inherited retinal degenerations and age-related macular degeneration affect more than two million people in the United States. For 90% of the people afflicted with these diseases, no treatments have been developed. This project will test a drug with strong therapeutic potential, and it will define a specific pathway involving AMPK and PGC-1 that can be activated to protect retinal neurons and RPE from inherited mutations and age-related degeneration. This in vivo study is designed to directly determine the role of mitochondrial gene expression and function as a contributing factor to inherited retinal degeneration and age-dependent macular degeneration.